Tuning translation efficiency to overcome refractory defects in CFTR

PROJECT SUMMARY (ABSTRACT)
Approximately 100,000 people worldwide are living with cystic fibrosis (CF), a lethal autosomal recessive
disorder caused by mutation of the CF transmembrane conductance regulator (CFTR). More than 2,100
disease-associated CFTR variants have been identified to date. Although deletion of phenylalanine 508
(F508del) remains the most commonly reported defect, ~13% of people with CF harbor premature termination
codons (PTCs) in CFTR. These variants result in little-to-no protein expression, as well as unstable mRNA
susceptible to degradation by nonsense mediated decay. CFTR PTCs are associated with more severe clinical
manifestations and are unresponsive to clinically approved therapies. An overarching goal of our work is to
identify cellular targets that might ameliorate disease by correcting the basic defect resulting from these
abnormalities. Our previous yeast phenomic analyses led to discovery of specific ribosomal proteins (RPs) as
effectors of F508del-CFTR trafficking. With K99/R00 support, we established that depletion of RPL12 (uL11)
rescues F508del by diminishing rates of translation initiation and elongation, thereby allowing the ribosome
and/or associated chaperones to promote a functional protein conformation. Findings outlined in the present
R01 demonstrate that suppression of RPL12 and other RPs such as RPL8 (uL2) also correct two rare PTCs,
W1282X- and G542X-CFTR. Thus, we hypothesize that ribosomal protein depletion alters translational
velocity, ribosome fidelity, and/or mRNA utilization to partially rescue synthesis and assembly of CFTR
nonsense variants. We will investigate this hypothesis according to three specific aims: (1) ascertain effect(s)
of ribosomal protein inhibition on biogenesis of CFTR PTCs; (2) define mechanism(s) by which silencing
ribosomal proteins alters translation kinetics and/or mRNA surveillance pathways to rescue CFTR nonsense
alleles; and (3) determine outcomes of ribosomal protein disruption in humanized CF mice. We will employ
multidisciplinary expertise directed towards mammalian physiology, biochemistry, molecular genetics, and
computational biology to mechanistically address a fundamental question regarding new ways the ribosome
influences mRNA utilization and protein structure. The studies are intended to establish translational control as
a novel and critical checkpoint during CFTR PTC processing, and identify specific ribosomal proteins in
addition to RPL12 and RPL8 that mediate this pathway. Such results will improve understanding of CF disease
mechanism, establish safety of repressing ribosomal proteins in CF animals, and provide a basis for testing
relevance of the strategy in other inherited human disease states. Emory University provides a rich
environment for support of early-stage investigators and leverages state-of-the-art facilities in a highly
collaborative academic research center. NIH support of the studies proposed in the current application would
catalyze the PI (Dr. Oliver) and her efforts towards strengthening academic research independence.

Public health relevance
PROJECT NARRATIVE Premature termination codons (PTCs) are causally linked to more than 2,400 severe genetic disorders such as cystic fibrosis (CF). Preliminary data outlined in this application demonstrate that partial suppression of specific ribosomal proteins restores biogenesis of CF nonsense alleles that are unresponsive to clinically approved interventions. We aim to elucidate mechanism(s) by which ribosomal inhibition corrects PTC processing, and determine relevance of this pathway in human and mouse CF models to inform potential new therapeutic strategies for overcoming nonsense variants.